Healthy and Livable Bronx Partnership

Abstract
BronxWorks, the Bronx’s largest multi-service organization, proposes to leverage its longstanding
partnership with the Citizens’ Committee for Children of New York (CCC) and the Albert Einstein
College of Medicine of Montefiore Medical Center (Einstein/Montefiore), to develop the Healthy
and Livable Bronx Partnership (HLBP). The structural intervention proposed is to increase access
to appropriately credentialed, reliable, and affordable childcare for working age adults who head
families who live in public housing complexes throughout New York City’s Bronx County.
New York City Housing Authority (NYCHA) is the largest administrator of public housing in the
United States. The Bronx has 75 public housing complexes consisting of 41,931 apartment units
home to 91,827 persons in 2021. It’s Permanent Affordability Commitment Together/Rental
Assistance Demonstration (PACT/RAD) initiative, launched in 2015, works in partnership with
privately-owned and operated real estate development corporations, property management
companies, and social service organizations, seeks to address longstanding issues that affect the
health of public housing residents.
HLBP builds on the Healthy and Livable Mott Haven Partnership (HLMHP) to identify and
transform the structures that drive poor health outcomes in one Bronx community. HLMHP’s
community-led engagement model collaborates with grassroots organizations, public housing
tenant leaders, government agencies, healthcare providers, advocacy groups, and human service
providers address a range of issues – food insecurity, nutrition, behaviors to promote healthy living,
access to open space and social connectivity.
Cardiometabolic and health service outcomes will leverage the Bronx Regional Health Information
(BxRHIO) health information exchange to acquire electronic health, psychosocial and care
management data.
(248 of 250 words)